A High-performance Shared Resource Super-resolution Spinning Disk Microscope

A. Project Summary
We request funds to purchase an Evident Scientific (Olympus) SpinSR, super-resolution spinning disk confocal
microscope. This spinning disk microscope will replace and update our now obsolete technology, and will also
provide a gentle, high-speed super-resolution method for live and fixed samples that our current structured
illumination microscopy platform (end-of-life January 2024) cannot provide. The SpinSR will be housed within
the Porter Biosciences Light Microscopy Core Facility (LMCF), located at the heart of the University of Colorado
Boulder main campus. Here we identify 12 Major Users and 3 Minor Users, from 4 departments, who contribute
to this proposal and will use the SpinSR. This User Group represents 18 active NIH awards (9 RO1, 5 R35, 1
DP, 1 R21 and 1 PO1,) and 1 HHMI award.
In 2015, we assembled a spinning disk microscope around a repurposed Yokogawa CSU-10A Nipkow
disk unit, which was built in August 2002. In 2017 we purchased a demonstration unit Yokogawa CV1000
spinning disk microscope that was built in 2011 and uses a Yokogawa CSU-X1 disk unit. We’ve maintained
these microscopes, and they have been essential for our Users, having supported at least 39 peer-reviewed
publications and numerous grants, doctoral and undergraduate honors theses, most from NIH-funded
laboratories. As these microscopes are becoming dysfunctional (detailed in Rationale section) and are severely
limited by today’s standards, our Users are increasingly unable to conduct their experiments, and they cannot
even pursue certain experiments due to limitations of technology.
Compared to our current spinning disk confocal microscopes, the SpinSR is more efficient, with a larger
FOV and faster performance, uses 6 lasers, has 2 cameras for simultaneous 2-wavelength imaging, performs
gentle, high frame-rate, real-time super-resolution, has expanded range high-speed optical sectioning, multipoint
photo-bleaching/photo-stimulation and superior optical performance. The science represented in our User Group
is diverse, ranging from mechanisms of proteasome quality control to – pair bonding in adolescents to – neural
tube biology – illustrating our need for a flexible and robustly configured spinning disk microscope. Our current
spinning disk and super-resolution capabilities cannot be serviced or updated, the microscopes and computers
depend on unsupported software and operating systems and cannot fulfill our current and future needs, severely
limiting our users. The SpinSR will address all the shortcomings of our current systems and enable our
Users to extend their research by offering new capabilities and technologies, helping them to be more
productive and make new discoveries, leading to high-impact papers and successful NIH grant
proposals.

Public health relevance
B. Project Narrative Spinning disk confocal microscopy is a critical resource for NIH-funded laboratories from across campus, where users rely on its flexibility, speed, sensitivity, and gentle imaging properties to execute their studies that pursue a variety of questions in human health. The SpinSR microscope will replace our obsolete technology and will allow for efficient, reliable, and reproducible data gathering as well as enable new discoveries. A new generation spinning disk microscope is not available as a shared resource at the university, and without one, our Users will remain limited and struggle to complete their studies and be unable to pursue new directions that the SpinSR system will provide for.